Endosomal mechanisms signaling oral cancer pain

PROJECT SUMMARY/ABSTRACT
GPCRs and RTKs are transmembrane receptors that control a host of physiological and pathological
processes including cancer pain and other forms of chronic pain. This proposal focuses on signaling
mechanisms of GPCRs and RTKs located in endosomes (eGPCRs and eRTKs) that might be responsible
for cancer pain. The underlying hypothesis is that eGPCRs and eRTKs generate long-lasting signals in
endosomes of human nociceptors and Schwann cells that induce sustained activation and sensitization to
mediate pain. Cells within the oral cancer microenvironment (cancer, immune, and neuronal cells), release
proteases, neuropeptides and growth factors that activate GPCRs (e.g., PAR2, CLR) and RTKs (e.g., TrkA,
EGFR) on nociceptors and Schwann cells. GPCRs and RTKs undergo clathrin-dependent endocytosis and
assemble signaling complexes that control activity and expression of ion channels and long-lasting
sensitization of nociceptors and Schwann cells to drive pain. A reverse translational approach is used to
study endosomal signaling of pain in 3 Specific Aims. Aim 1 determines the contribution of eGPCR and
eRTK signaling to pain. Oral cancer patient pain will be evaluated (questionnaires, sensitivity testing of
patient oral cancer tumors with mechanical and chemical stimuli, and assessment of comorbidities).
Surgically resected tumors, trigeminal nerve, and cancer supernatant will be collected. Patient-specific
Schwann cells will be isolated and cultured from the nerve. Nociceptors and Schwann cells will be obtained
from organ donors. Nociceptive effects of cancer supernatant, proteases, neuropeptides, and growth
factors that mediate activity of nociceptors and Schwann cells will be studied in mice. Endocytosis inhibitors
will be used to probe the link between endocytosis and nociception. Sensitization and nociception will be
correlated with individual patient pain phenotypes. Aim 2 Defines eGPCR and eRTK pain signaling
mechanisms. Effects of cancer supernatant, and eGPCR and eRTK ligands will be studied. Endocytosis of
GPCRs and RTKs that mediate oral cancer pain will be studied in human and mouse nociceptors and
Schwann cells by confocal imaging and biophysical assays. Biosensors will be used to study the assembly
of multiprotein signaling complexes in subcellular compartments of nociceptors and Schwann cells.
Endosomal signaling will be correlated with pain phenotypes in individual patients. Aim 3 develops
nanoparticles (NP) to antagonize eGPCR and eRTK signaling in preclinical pain models that recapitulate
patient oral cancer pain. Endosomal acidity and light will be exploited to trigger NP disassembly and
antagonist release, and test contributions of eGPCR and eRTK signaling. Their use in preclinical pain
models will link endosomal signaling to pain. A deeper understanding of eGPCR and eRTK signaling
mechanisms will provide insight into the neurobiology of oral cancer pain.

Public health relevance
PROJECT NARRATIVE Oral cancer patients suffer from severe pain, especially while eating and talking. The proposal investigates whether G protein-coupled receptors (GPCRs) and receptor tyrosine kinases (RTKs) generate sustained signals from endosomes that mediate sensitization of human nociceptors and Schwann cells and thereby cause oral cancer pain. A deeper understanding of GPCR- and RTK- mediated pain signaling in humans will provide insights into the mechanism of oral cancer pain.